Mitochondrial 2-hydroxyglutarate dehydrogenases modulate the cellular epitranscriptome

There is increasing recognition of mitochondria as signaling organelles. An important facet of this “adjunct”
mitochondrial function is epigenetic modulation, as exemplified by the generation of acetyl-CoA and S-
adenosylmethionine used in the acetylation and methylation, respectively, of DNA and histones. In addition,
alpha-ketoglutarate (αKG) and 2-hydroxyglutarate (2-HG), metabolites generated almost exclusively in the
mitochondria, are found to modulate the activity of αKG-dependent dioxygenases, including TET DNA
hydroxylases and histone demethylase (HDM), thus controlling DNA and histone methylation. Notably, our
group discovered that αKG activates and 2-HG inhibits FTO and ALKBH5, RNA demethylases that act on N6-
methyladenosine (m6A), a reversible chemical modification of mRNA (the epitranscriptome) that influences
gene expression. Similar to other epigenetic marks, RNA methylation is dynamically controlled and m6A
abundance influence various biological functions, while its misregulation associates with human diseases.
Considering that αKG/2-HG are generated mainly by intermediary mitochondrial metabolism, and that the
activity of RNA demethylases are modulated by these metabolites, it is reasonable to speculate that
mitochondria play an important role in the control of RNA methylation homeostasis. In particular, we postulate
that the mitochondrial enzymes D-2- and L-2-hydroxyglutarate dehydrogenase (D2HGDH and L2HGDH),
which catalyze the interconversion of 2-HG to αKG, are integral to the interplay between mitochondrial
metabolism and the control of RNA methylation. This hypothesis is supported by our earlier discovery that loss
of function D2HGDH mutations leads to decreased activity of the αKG-dependent TET and HDM enzymes. We
recently expanded on this concept by identifying upstream signals that regulate D2HGDH and L2HGDH
expression/activity. Using ChIP assays, inducible cell lines and a transgenic mouse model we discovered that
MYC transcriptionally activates D2HGDH and L2HGDH, and that in a D2/L2HGDH/αKG-dependent manner it
induces FTO and ALKBH5 function leading to RNA demethylation in vitro and in vivo. Remarkably, we found
that the MYC-D2/L2HGDH-αKG axis also promotes the nuclear accumulation of FTO and ALKBH5, in
association with enhanced O-GlcNAcylation, a post-translational modification executed by another
mitochondrial enzyme, O-GlcNAc transferase (OGT). Here, using multiple genetic models in vitro and in vivo,
we will test the hypothesis that a novel mitochondrial signaling axis, which includes MYC at the proximal point,
D2/L2HGDH and OGT at the center, and, distally, FTO/ALKBH5 activity, controls the cellular epitranscriptome.
Our specific aims are: 1) characterize the contribution of D2HGDH/L2HGDH and of intermediate metabolites to
the control of m6A levels, 2) determine the mechanistic basis for the increased O-GlcNAcylation mediated by
the MYC-D2/L2HGDH-αKG axis and its role in promoting RNA demethylation, 3) define a mitochondrial
metabolism-dependent methylRNA/gene expression signature in human cells.

Public health relevance
Metabolism plays a significant role in human physiology and pathology. A better understanding of this interplay may uncover opportunities that could be exploited therapeutically. We will test the concept that intermediary mitochondrial metabolism is a key regulator of RNA methylation, a newly recognized epigenetic modification that is abnormal in multiple human conditions.